Nevada Pregnancy Risk Assessment Monitoring System

Abstract
Component A: Core Surveillance
Nevada Pregnancy Risk Assessment Monitoring System (PRAMS):
RFA-DP-21-001
Abstract
Existing data suggest numerous Nevada maternal and infant health outcomes are
unfavorable compared to national rates and HRSA Maternal and Child Health Bureau
indicators. Nevada falls below the US national average for critical outcomes such as
prenatal care and preventive medical visits, and has higher rates of cesarean deliveries,
early term births, low birth weight deliveries, postneonatal mortality, and neonatal
abstinence syndrome. For many indicators racial disparities exist like those experienced
nationally; in particular, Black mothers and infants in Nevada experience disproportionally
increased rates of sudden unexpected infant death, postneonatal mortality, and cesarean
deliveries. Data sets such as vital records provide limited data to explore the risk factors
associated with these outcomes. This award will expand Nevada’s ability to examine
these outcomes. Nevada does not have any other comprehensive system available to
monitor perinatal trends to guide program activities, health policy, and resource allocation.
PRAMS will enable Nevada to implement surveillance activities of high scientific quality
on selected maternal attitudes, behaviors, and experiences that occur before, during, and
after pregnancy. Nevada PRAMS data will help elucidate the reasons for maternal
behaviors, such as choosing not to breastfeed or not seeking prenatal care and will help
determine the prevalence of domestic/intimate partner violence, postpartum depression,
and contraceptive use. PRAMS data will be used to make data-driven programmatic
decisions to tailor activities to improve birth outcomes and systems of care for Nevada
mothers and children and enhance the State’s capacity to evaluate the impact of program
activities.

Public health relevance
Narrative Component A: Core Surveillance Nevada Pregnancy Risk Assessment Monitoring System (PRAMS): RFA-DP-21-001 Project Narrative The Nevada Pregnancy Risk Assessment Monitoring System (PRAMS) will improve surveillance of maternal and infant health key indicators such as infant morbidity and mortality, access to prenatal care, and maternal behaviors during pregnancy and early infancy. Data obtained from this surveillance will be used to shape maternal and child health programs and policies in Nevada. PRAMS will advance the Nevada Division of Public and Behavioral Health (DPBH), Maternal, Child, and Adolescent Health (MCAH) Section’s mission to improve the health of mothers and infants statewide.